Durability of Epithelial Defects in Crohn's Disease Intestine

PROJECT SUMMARY/ABSTRACT
Crohn’s disease is a debilitating and progressive inflammatory disease of the gastrointestinal tract. Defects in
epithelial cells are thought to contribute to Crohn’s disease progression. However, the biological drivers and
mechanisms of epithelial defects are not well understood. If epithelial cell defects occur secondary to the
inflammatory and altered microbiome exposures present in the patient, treatments targeting these exposures
would be predicted to resolve the epithelial defects. Alternatively, if epithelial defects are primary or durable
contributors to Crohn’s disease progression, they would be predicted to persist despite treatment, as no current
treatments target the epithelium. This project aims to distinguish these two models in order to improve Crohn’s
disease prognosis. We have identified two quantitative epithelial defects related to microvillar dysfunction in
Crohn’s disease ileal tissues lacking histological inflammation, suggesting that microvillar defects could be
durable contributors to Crohn’s disease progression. Microvilli are apical membrane protrusions on epithelial
cells that increase surface area for absorption and provide a physical location for the enrichment of enzymes,
transporters, and host defense proteins critical for intestinal homeostasis. Loss of microvilli or certain microvillar
localized proteins is associated with microvillus inclusion disease, very-early onset inflammatory bowel disease,
and enteropathy. For this project, we propose to track the quantitative microvillar defects in vivo (pre- and post-
treatment) and in vitro (epithelium removed from inflammatory/microbial exposures). We have developed an
overarching hypothesis that epithelial microvillar defects will be durable in a Crohn’s disease patient subset with
a more aggressive disease course. In Aim 1, we will investigate the durability of the microvillar defects in vivo
using existing longitudinal samples and data from the pediatric RISK Crohn’s disease cohort and control
subjects. We predict that the microvillar defects are more likely to persist in patients with progressive disease
behavior, lack of anti-TNF response, and requirement for surgery. We will also perform association analysis with
the microvillar defect phenotypes, clinical parameters, and microbiome profiles to identify ways we can potentially
improve patient subsetting. In Aim 2, we will investigate the durability of the microvillar defects in vitro using
human intestinal epithelial spheroid lines derived from Crohn’s disease and control patient biopsy tissues. Our
preliminary analysis indicates that the microvillar defects will be durable in a subset of spheroid lines. We will
test if durable spheroid microvillar defects are associated with decreased lipid metabolism, a critical enterocyte
function predicted to be decreased by our preliminary analysis. Overall, this project will determine whether
microvillar defects are durable epithelial contributors to Crohn’s disease progression. In addition, it will begin to
identify the Crohn’s disease patient subset that would be most likely to benefit from a personalized therapeutic
approach to restore epithelial cell function.

Public health relevance
PROJECT NARRATIVE Personalized therapeutic strategies to promote mucosal healing in specific Crohn’s patient subsets is critical because the majority of Crohn’s disease patients still experience disease progression and require surgical intervention, despite access to multiple therapies targeting the immune response. This proposal will determine if previously identified defects of Crohn’s disease patient intestinal epithelial cell microvilli are durable in vivo and in vitro and associated with progressive disease outcomes. The ultimate goal is to understand if these epithelial defects contribute to Crohn’s disease progression and should be considered in personalized therapeutic strategies.